Correlative cryoET of the HIV-1 integration targeting in native T-lymphocytes

Title: Correlative cryoET of the HIV-1 integration targeting in native T-lymphocytes
Project Summary
Retroviruses, including human immunodeficiency virus type 1 (HIV-1), integrate their genetic material into the
host cell genome during their replication cycle. In the case of HIV-1, upon entering a host cell, viral RNA is
reverse transcribed into a double-stranded viral DNA (vDNA) by the viral reverse transcriptase. This vDNA, along
with other viral and cellular proteins, forms a preintegration complex (PIC), which translocates into the host cell
nucleus to the gene-dense transcriptionally active open chromatin regions where the viral DNA is inserted into
the host cell genome by viral integrase. Integration is an essential step for establishing a persistent infection in
the host.
The integrated viral DNA becomes part of the host cell's genome as proviral DNA and its positioning within the
chromatin architecture plays a pivotal role in HIV-1 pathogenesis. While extensive data from genetic, biochemical
and imaging studies point to integration targeting at gene-dense and transcriptionally active chromatin, the
chromatin architecture at these sites, however, has remained elusive. This is largely due to the difficulties in
obtaining high-resolution in situ images of native chromatin in intact cells using cryoET, further compounded by
the challenges to locate the integration targeting sites through correlative approaches. Building on our recent
exciting results on resolving individual nucleosome and chromatin fiber structures within intact native T-
lymphocytes using cutting-edge cryo-focused-ion-beam technology (cryoFIB) and cryoET, we aim to address
these challenges by developing novel correlative technologies for integration targeting and determine their
architectures using advanced in situ structural biology methodologies. Specifically, we will create capsid and
integrase dual-labelled virions, develop Quantum Dot labelling of vDNA, along with fluorescence labelling of host
factors in T-lymphocytes for the correlative approaches to determine the molecular architecture of integration
targeting sites. We will further investigate structural alterations resulting from changes in the integration targeting
by disrupting crucial interactions between HIV-1 and host factors. The proposed research will not only fill a critical
knowledge gap in our understanding of HIV-1 integration targeting but also push the boundaries of correlative
and in-situ cryoET to achieve resolutions previously considered unattainable, facilitating progress in studies
beyond those proposed here.

Public health relevance
Title: Correlative cryoET of the HIV-1 integration targeting in native T-lymphocytes Project Narrative HIV-1 infection remains a global health concern. While the past 30 years have seen a dramatic increase in the life expectancy of individuals living with HIV, however, there is still no reliable treatment to eradicate HIV-1 from its human host and no vaccine to protect the society from new infections. One of the reasons underlying the persistence of HIV-1 is its permanent integration into the host’s genome, where the structure of chromatin plays a pivotal role. Understanding chromatin architecture of HIV-1 integration targeting and the interplay between HIV-1 and host chromatin hold the promise of informing strategies to disrupt latent infections and aid in the development of innovative therapies targeting the viral-host interface.